Mechanistic characterization of SARS-CoV2 associated kidney injury

SARS-CoV2 is a highly contagious, novel human coronavirus that causes coronavirus disease 2019 (COVID-
19). Currently over 16.5 million people in the US have confirmed infection with SARS-CoV2 and over 300,000
have died. Severe COVID-19 is characterized by pulmonary and systemic inflammation and multi-organ
dysfunction, with a significant portion of severe COVID patients developing acute kidney injury. The mechanism
by which SARS-CoV2 triggers such severe pathogenesis is poorly understood. Recent clinical studies have
suggested that cell death, especially the induction of necroptosis, may be a predictor of severe COVID-19
disease. The mechanism by which the host restricts necroptosis is unclear. In preliminary data we have shown
that the interferon induced protein, ISG15, acts as a negative regulator of necroptosis and its downstream
inflammatory responses during viral infection. We have also shown that ISG15 deficient mice rapidly succumb
to ischemia-reperfusion injury of the kidney characterized by a massive release of proinflammatory cytokines.
In this proposal we will test the hypothesis that ISG15 serves as a critical host restriction factor in regulating
programmed necroptosis and downstream inflammatory responses within the kidney to limit acute kidney injury
during SARS-CoV2 infection. We will utilize kidney organoids derived from induce pluripotent stem cells in which
ISG15 has been deleted by CRISPR, a co-culture system with kidney organoids and primary tracheal epithelial
cultures (hTECs), and in vivo mouse model of SARS-CoV-2 to ask several questions including: 1) Does SARS-
CoV2 induce damage to kidney epithelial cells via direct viral transduction or in response to systemic
inflammation?; 2) Does ISG15 modulate necroptotic cell death as well as proinflammatory cytokine/chemokine
production in kidney epithelial cells during SARS-CoV2 infection?; 3) Does necroptosis and its regulation by
ISG15 contribute to acute kidney injury during SARS-CoV2 infection? Overall, our studies will provide important
insight into host factors that restrict necroptosis and could be an important contributor to severe COVID-19
induced kidney injury.

Public health relevance
Project Narrative SARS-CoV-2 is a highly contagious, novel human coronavirus that causes COVID-19, which has killed more than 300,000 individuals in the United States alone. Patients with severe disease often have complications in organs outside the lung, including acute kidney injury. The goal of this work is to evaluate whether excessive inflammatory cell death, regulated by the host factor ISG15, acts as a key regulator of acute renal injury during to SARS-CoV-2 infection.